The role of plasmacytoid dendritic cells in corneal immunity

SUMMARY
The cornea is among the few tissues that enjoy immune privilege, however, corneal immune privilege is
not absolute. In many corneal diseases, including infectious keratitis, dry eye disease, and corneal
injuries, infiltrating leukocytes can advance disease progression. Our preliminary results suggest that
plasmacytoid dendritic cells (PDCs), which reside in the cornea during steady state, actively participate
in the maintenance of corneal immune homeostasis, as their depletion leads to enhanced corneal
leukocyte infiltration and amplified adaptive immune responses in draining lymph nodes (dLNs). Thus, in
this application, we propose to evaluate the significance of PDCs in the maintenance of tolerance and
the mechanisms through which PDCs contribute to corneal immune homeostasis. We will identify
potential candidates through single cell sequencing of PDCs. We aim to study the role of PDCs in
mediating multiple steps involved in the process of inflammation, from leukocyte recruitment to the
cornea, antigen uptake and processing by antigen presenting cells, their egress to, and antigen
presentation in dLNs, and priming of T cells. Additionally, we have observed that PDCs interact directly
with T cells in the dLNs, and support development and stabilization of regulatory T cell (Tregs),
important immunosuppressive lymphocytes. We aim to analyze the molecular mechanisms by which
PDCs induce and maintain Tregs, as well as examine the clinical utility of adoptive transfer of PDC-
induced Tregs in infectious keratitis, dry eye disease and corneal transplantation. We also propose to
study the feasibility, efficacy, and potential local and systemic side effects of local adoptive transfer of
PDCs to the cornea for the treatment of immune and inflammatory diseases. Next, we aim to evaluate
therapeutic efficacy of local adoptive transfer of PDCs or application of PDC secretome in limiting clinical
severity of the disease, infiltration of leukocytes, disease progression, and complications in models of
dry eye disease and herpes simplex keratitis. This application proposes a paradigm shift on how PDCs
modulate immunity, and could result in the introduction of new immunomodulatory therapeutic
avenues for ocular as well as systemic inflammatory, autoimmune, alloimmune and infectious diseases.

Public health relevance
We propose to investigate the role of plasmacytoid dendritic cells in the maintenance of corneal immune homeostasis, and their effects in dampening corneal immune responses. We will investigate the molecular mechanisms by which plasmacytoid dendritic cells have immunomodulatory effects on innate and adaptive immunity. Further, we aim to assess the therapeutic efficacy of local adoptive transfer of plasmacytoid dendritic cells or topical treatment with their secretome in ameliorating corneal inflammation in clinically relevant models of dry eye disease, herpes simplex keratitis, and allogeneic corneal transplantation.